Quantitative Normalization of Spatial Metabolomics for Molecular Signatures of Tissue Heterogeneity

PROJECT SUMMARY
The molecular and biochemical basis of tissue heterogeneity in normal and disease states can
be addressed with spatial omic analysis. Advances in spatial metabolomic analysis of tissue
biopsies using MALDI-MSI could enable the identification of numerous biochemical pathways as
signatures of specific histopathology features. However, to extract the most robust disease-
relevant biomarkers and pathways from spatial omics platforms will require quantitation of spatial
molecules for automation and statistical analysis. A key obstacle to adoption of spatial
metabolomics is the lack of rigorous normalization of biomolecules across tissue sections.
SygnaMap proposes to build MSI-DeepPath as a computational platform to quantify spatially
distinct metabolite abundancies with histopathologic features. Data from MALDI-MSI and bulk
metabolomics from serial sections of human kidney and liver tissue will be used as the data source
for our platform development. SygnaMap is developing MSI-DeepPath, a drug discovery and
development computational platform that incorporates ground-breaking improvements in MALDI-
MSI with computational pathology. Quantitation of spatial metabolomics for automation and
statistical analysis as presented in this SBIR proposal will enable the extraction of the most robust
disease-relevant pathways from metabolites. The rigorous deconvolution of structure-relevant
pathways will enable a highly impactful therapeutic target discovery and drug development
platform for use by biotech and pharmaceutical companies for development of therapeutics
alongside biomarkers.

Public health relevance
PROJECT NARRATIVE Existing spatial technologies may not provide detailed information on metabolic pathways while spatial metabolomics using mass spectrometry imaging data could map biochemical functional pathways with histologic features. With the MSI-DeepPath computational platform at SygnaMap, we will enable quantification of key biomolecules from mass spec imaging data.